GENETIC LINKAGE STUDY OF SCHIZOPHRENIA

It is proposed to study 90 sib-pairs with the disorder. Specific aims are: (1) to clinically assess a pedigree sample having adequate power to detect genes for schizophrenia; (2) to conduct a genome scan to find such loci; and (3) to transmit all data to the NIMH designated cell repository and data management centers. The goals will be attained by achieving the following: (1) from Taiwan and China, 900 Han Chinese sib- pairs having DSM-IV schizophrenia will be collected. (2) The investigators will examine all family members using the Diagnostic Interview for Genetic Studies and the Family Interview for Genetic Studies. The PI participated in the development and field testing of these interviews and has an already established training program for their use. They have been translated into Mandarin by the Taiwanese investigators, who have used them in prior studies. (3) Blood samples will be sent to the NIMH designated cell repository for creation of lymphoblastoid cell lines. (4) Clinical data will be entered using the database software created for the NIMH Human Genetics Initiative. Data will be vetted and sent to the NIMH designated data management center. (5) The investigators will complete a genome scan using 450 markers spaced at an average of 10 cM intervals using markers that have been optimized for use in the Han Chinese population. The scan will be completed with no cost to the NIMH through an agreement with Millenium Pharmaceuticals, a biotechnology company in the Boston area that the PI has worked with on a prior genetic linkage study of schizophrenia. All genetic analyses will be approved by the consultant, Eric Lander, Ph.D. (6) all clinical data will be made available to the scientific community by the end of the funding period. All genotypes will be available on year after they are created but no later than a year after the funding period. This project is feasible because: (1) The PI has already coordinated one multi-site genetic linkage study of schizophrenia and has participated in a second. (2) The investigators have a longstanding relationship with the Taiwanese collaborators and an effective, albeit, more recent working relationship with the Chinese collaborator. (3) The investigators have conservatively estimated that each site has access to more than enough available families having two schizophrenic siblings. (4) The PI's Harvard team has had prior experience collaborating on genotyping and linkage analysis projects with Millennium Pharmaceuticals. This, and Millennium's prior genotyping experience shows that the genotyping phase of the work is feasible.